CRCNS:US-lsrael Research Proposal: To Elucidate Fundamental Mechanisms of Transformed Saliency Map to

The neural bases of sensory stimulus selection, an essential function for attentional and adaptive behavior, will be investigated by
this collaborative project in barn owls, a specialized stimulus localizer species. While a topographic representation of relative
stimulus strength and behavioral relevance across visual and auditory space has been demonstrated in the barn owl's optic tectum
(OT), how the information is conveyed to downstream decision-making centers for proper control of stimulus driven behaviors is
unknown in barn owls, as well as in other species. The main goal of the proposed research is to understand the read-out
mechanisms of the midbrain map in the ascending midbrain-to-forebrain pathway, along which a transformation involving
abolishment of a topographic representation of spatial location is observed. Barn owls offer a strong advantage for investigating
these questions, because of their robust and well-studied visual and auditory representations across brain regions and because a
robust auditory saliency map has been shown in the barn owl. This study aims at answering the question of how behaviorally
relevant sensory signals are selected and encoded to induce stimulus location driven perceptual and behavioral responses while
others are ignored. Through simultaneous recordings of midbrain, thalamic and forebrain regions, the hypothesis that topographic
representation of salient stimuli is translated into a non-topographic representation of salient stimuli for both visual (Aim 1) and
auditory (Aim 2) salient stimuli will be tested in both anesthetized and behaving animals. Computational modeling describing
network processing and coding will be used for further testing hypothesis and detailed description of network and coding
mechanisms underlying transformational coding of stimulus selection (Aim 3). Preliminary results support feasibility of proposed
approaches. This collaborative computational project will contribute intellectual merits and broader impact of widening view and
understanding of neural coding and network mechanisms underlying stimulus selection by a transformational coding scheme from
midbrain to forebrain, fundamental for selective attention and perception of salient stimuli across species. Innovative simultaneous
recordings of midbrain and forebrain regions of anesthetized and awake animals, and interdisciplinary physiological, behavioral and
computational approaches will be implemented. In addition, training opportunities and publication goals for undergraduate,
graduate and postdoctoral fellows will enhance their visibility and career plans. Related to diversity and inclusion, the team includes
members from underrepresented gender and ethnic groups and will promote international collaboration in brain sciences.

Public health relevance
Conceptual significance: Results of this research are expected to have high impact on our understanding of mechanisms of processing and coding of salient stimuli along sensory pathways. The proposed research project aims to test fundamental qualitative changes in coding frameworks of auditory and visual pathways and investigate underlying processing and information flow mediating these changes, a novel and promising research that could explain how salience of sensory inputs is processed and encoded in the brain, which is fundamental to how we perceive and interact with the world around us. Technical significance: The proposed action uses innovative multielectrode recording techniques in awake and behaving animals to understand flow of information and coding of salient stimuli from midbrain to forebrain audiovisual regions. In addition, it will implement and interdisciplinary approach, combining recording of neuronal population responses and computational modeling of coding and processing schemes.